Administrative Core

SUMMARY
The FIRST Cohort program is housed within the Center for Scientific Diversity (CSD) at the Icahn School of
Medicine at Mount Sinai (ISMMS) in collaboration with Institutes and Departments across ISMMS and with the
support of institutional leadership. The mission of the CSD is to foster, develop, and assess empirically
supported practices that promote and enhance scientific innovation, diversity, and equitable advancement within
the biomedical investigator workforce. This Administrative Core will serve as the conduit among and between
FIRST Cohort program stakeholders across the institution to advance our overarching goal to develop and
sustain a culture of inclusive excellence. The Administrative Core will assist in all aspects of the administration,
communication, and overall conduct of the FIRST Cohort program. It will act to advance the FIRST Cohort
program goals which are to 1) integrate and modify existing and evolving strategic plans to achieve systemic
and sustainable culture change; 2) recruit a FIRST cohort of four clusters of three scientists each from
underrepresented groups in biomedical research (URM) and/or who have a demonstrated commitment to
promoting diversity and inclusive excellence to be embedded within and across The Friedman Brain Institute
(FBI), The Institute for Health Equity Research (I-HER), the Tisch Cancer Institute (TCI) <NIH-funded National
Cancer Institute> and the Global Health and Emerging Pathogens Institute/Microbiology and Infectious Disease;
and 3) develop strategies to support the research and career development of FIRST cohort faculty, including
plans to reduce isolation and build community. The Administrative Core will provide support for personnel
involved in the administrative, scientific, communication, and budgetary oversight functions associated with the
proposed FIRST Cohort program. Our aims are designed to advance the goals for this application at the Icahn
School of Medicine at Mount Sinai while developing evidence-based best practices for inclusive excellence more
broadly for the national biomedical research enterprise. To that end, the aims of the Administrative Core are
leadership, administration, communications, integration across Cores, recruitment of a diverse cohort and
oversight of advancement/promotion and retention activities and tracking and evaluation. We will coordinate with
the Faculty Development Core to provide metrics of success. The AC is responsible for oversight of all activities
and initiatives associated with the FIRST Cohort Program to create and sustain a culture of inclusive excellence.
We will coordinate with the NIH under the terms of the Cooperative Agreement Award and participate in NIH
First Executive Steering Committee meetings.